LARGE-SCALE PROCESSING OF BIOLOGICAL MATERIALS

The Pilot Plant is involved in large scale growth of microorganisms and mammalian cells, and in large scale isolation and purification of biologically active components from these sources and from other sources such as mammalian or plant tissues. We assist NIH investigators in the scaling up of processes by conducting research and development work for the appropriate approach suitable of the large scale processing.